Selecting and Testing Implementation Strategies to Advance Measurement-based Care in School Mental Health

Selecting and Testing Implementation Strategies to Advance Measurement-based Care in School Mental
Health
PROJECT SUMMARY:
Annually, between 14-20% of children and adolescents are diagnosed with a mental illness, and only about
half receive treatment. Although a large proportion of services received are school-based, the delivery of
evidence-based practices in school mental health (SMH) is highly inconsistent. A vital opportunity to improve
SMH quality is the successful implementation of measurement-based care (MBC). MBC involves clinicians’
routine use of brief, reliable and valid student- or parent-reported symptom and functioning data to monitor
progress and inform treatment decisions. MBC is an evidence-based practice associated with greater and
faster reduction of symptoms, improvements in functioning, patient engagement and shared decision-making.
Despite evidence of effectiveness and good fit with school settings, MBC use in SMH practice is limited.
The goal of this K08 is to select and pilot test a set of school context-specific implementation strategies to
facilitate MBC among SMH clinicians. With training and advanced mentorship from outstanding scientists in
mental health services research, measurement-based care, and implementation science such as Drs. Melanie
Bennett, Mark Weist, Sharon Hoover, John Landsverk, Clayton Brown, Richard Goldberg and Aaron Lyon, and
as a faculty member at the only national Center for School Mental Health, I am ideally positioned to lead
school-based implementation research with additional training in four areas: (1) training clinicians in MBC tools
and processes; (2) implementation strategies, frameworks, research design; (3) multilevel modeling and mixed
methods and (4) scientific writing and research-to-practice partnership skills. The research plan will involve
purposively sampling 25 SMH Stakeholder Expert Panelists (i.e., SMH clinicians, services administrators,
education leaders, clinical researchers, implementation intermediaries and implementation scientists) from the
National SMH Census to identify and achieve consensus on implementation strategies specific to MBC in SMH
via a modified Delphi process. Next, Panelists will engage in an established Concept Mapping method to
organize and rate strategies to inform strategy selection. Finally, we will pilot test selected strategies with 30
SMH clinicians in two districts using a multiple-baseline implementation trial to test the effect of implementation
strategies on MBC implementation (i.e., fidelity, acceptability, appropriateness, feasibility) and observe the
effect of MBC use on student outcomes and patient engagement. By partnering closely with SMH clinicians
and stakeholders, this project offers the opportunity to identify and adapt or develop implementation strategies
that are feasible, scalable and ecologically-valid to promote the uptake of MBC among front line SMH
clinicians. The mentored training and research experiences afforded by this K08 will provide the foundation for
a future R01 submission to conduct a fully-powered Hybrid design testing the implementation and
effectiveness of MBC strategies in SMH. The skills I obtain will equip me to develop an independent program
of research as an implementation scientist focused on improving the quality of mental health care in schools.

Public health relevance
Development and Pilot Testing an Implementation Framework to Advance Measurement-based Care in School Mental Health PROJECT NARRATIVE: School-based treatment accounts for up to 70-80% of mental health services received, illustrating the major public health impact of integrating mental health in education and ensuring that these services are evidence- based. Measurement-based care is an effective, evidence-based practice that applies to numerous treatment approaches and presenting concerns, and is well-suited to school settings. Scientific discovery about successful implementation strategies to increase broadly-applicable evidence-based practices, including measurement-based care, in schools will improve school mental health care quality in the short term and reduce the burden of mental illness for affected children and their families in the long term.